Human pluripotent stem cells for the study of gastrointestinal dysmotility

Abstract

The enteric nervous system (ENS) accomplishes a broad range of activities that rely on a remarkably
diverse population of neuronal and glial subtypes. Loss of specific cell types, such as nitric oxide (NO)
producing neurons (nitrergic neurons) leads to enteric neuropathies associated with dysmotility
disorders including esophageal achalasia, gastroparesis and infantile hypertrophic pyloric stenosis. The
underlying pathophysiology of these disorders have remained largely unknown due to limitations of
currently available cellular models. We have recently reported a new alternative approach for
differentiation of ENS lineages from human pluripotent stem cells under fully defined conditions,
providing a unique and reliable framework for ENS disease modeling and drug discovery. Taking
advantage of high content chemical compound screening in combination with fate map reconstruction
guided by single cell transcriptomics, here we propose a new strategy for efficient derivation and
prospective isolation of enteric nitrergic neurons. This system will provide a unique in vitro model for
identification of pharmacological regulator of these neurons and dissection of cellular mechanisms that
underlie GI dysmotilty. We will further evaluate the potential of these neurons in transplantation studies
aimed at the ultimate development of cell-­based treatment of enteric neuropathies related to the loss
of nitrergic neurons.

Public health relevance
Project Narrative The cellular pathophysiology of gastrointestinal motility disorders are extremely complex and elusive. Damage or loss of enteric inhibitory motor neurons is responsible for a broad range of gut motility disorders. Here, taking advantage of human pluripotent stem cell differentiation, we propose to establish an innovative framework to establish a new cellular model for the study enteric inhibitory neurons and an experimental pipeline for cell replacement therapy in GI dysmotility.